Bacterial and Viral Predator-Prey Dynamics within Bacterial Biofilms at Cellular Resolution

PROJECT SUMMARY
The Nadell lab studies the spatial mechanics and community dynamics of bacterial biofilms, using Vibrio
cholerae, V. parahaemolyticus, Escherichia coli, and their respective bacterial and viral predators as model
systems. While some marine Vibrio species cause human disease, with cholera being the most historically
important, my lab does not study virulence mechanisms or bacterial pathogenesis. Rather, we use these species
to understand the architectural and community dynamics of live biofilms at cellular resolution. Most bacteria
produce surface-bound biofilm communities in nature, but we have strikingly little understanding of how cell-cell
interactions lead to their higher order composition, architecture, and community dynamics. Since biofilm structure
and composition can contribute to their role in acute and chronic infection, understanding the mechanisms
controlling their structure and composition, and in particular how predatory viruses and bacteria attack biofilm-
dwelling cells, may lead to novel approaches to fight clinical infections. Over the next five years we will focus on
two major frontiers that have received minimal attention using cellular resolution imaging in the biofilm field thus
far. First, no work thus far has examined how temperate phages interact with biofilms at high resolution;
temperate phages can amplify and kill susceptible bacteria, but they can also integrate into the bacterial genome
and amplify passively along with the host bacterial cell. This phage life history is widely important in nature and
in host microbiota, and indeed often affects bacterial virulence. We will study in detail where and when within
biofilms these temperate phages infect and kill target bacteria, and where they integrate into the host genome.
Further, we will rigorously compare the propagation dynamics of temperate phages and lytic phages within
biofilms to understand how these fundamentally distinct life history strategies influence phage and bacterial
fitness in realistic environments. Second, the vast majority of high-resolution biofilm research has focused on
biofilms grown on glass under flow of nutrient media. Many realistic environments, including those of marine
Vibrio bacteria, are not this simple, with biofilms growing on topographically complex substrates, and with
nutrients derived directly from the underlying surface rather than the surrounding liquid media. We will explore
the consequences of these complex topographical environments by cultivating multispecies biofilms of V.
cholerae and V. parahaemolyticus growing on and consuming particles of shrimp shell chitin. This system will
permit us to study how growth in a multispecies context on naturalistic substrates influences community
architecture and dynamics. Lastly, we will rigorously test how the realistic chitin environment influences the ability
of a ubiquitous bacterial predator, Bdellovibrio bacteriovorus, is able to attack and kill Vibrio prey within single
and multispecies biofilms. Our research will expand along two important new frontiers, both of which will yield
insight into how predatory viral and bacterial species kill prey bacteria dwelling in otherwise protected biofilms.

Public health relevance
PROJECT NARRATIVE Acute and chronic bacterial infections often entail microbial biofilm growth, rendering pathogens difficult or impossible to remove with out surgical resection. My lab studies how cell-cell and cell-surface interaction lead to higher order biofilm architecture, composition, and community dynamics. Here we propose to study how predatory viruses and bacteria propagate among prey bacteria inside biofilms, which can inform how novel alternative antimicrobial strategies could be used against biofilms where traditional antibiotics fail.